Developmental Research Program

Project Summary/Abstract of the Development Research Program
The Developmental Research Program (DRP) will provide key support to develop novel translational
early-phase Projects in the area of cancer disparities that, ultimately, will contribute to the reduction in the
morbidity and mortality of cancer among medically underserved populations. In line with the overall goals of
our Translational Research Program in Colorectal Cancer Disparities. The DRP will foster new collaborations
between participating institutions and initiate collaborations with other SPOREs and Disparities P20’s.
Additionally, our Career Enhancement Program (operated through our Administrative Core) will encourage
early career investigators, particularly those from racially/ethnically diverse backgrounds, to apply to the DRP.
Our goal is to fund Developmental Research Projects encompassing a range of translational cancer disparities
research, including molecular biology, epidemiology (primary and secondary prevention), early detection,
prognosis, therapeutics, and survivorship. To achieve this goal, we will identify promising translational cancer
disparities Research Projects through broad solicitation (Aim 1). We will encourage early and senior
investigators to collaborate across multiple disciplines. New ideas will be solicited on an annual basis by
broadly advertising pilot funding and targeted engagement with promising faculty. Aim 2 will focus on rigorous
and balanced scientific review of DRP proposals. We will convene an expert panel encompassing a broad
range of scientific disciplines and also include participation from our Community Advisory Board. We will follow
the National Institutes of Health SPORE guidelines for these reviews. In addition to financial support, funded
DRP Projects will receive strong infrastructure support and access to biospecimens and expertise related to
novel technologies through our Administrative and Biospecimen and Pathology Cores (Aim 3). With our
generous institutional matching support we will award $100,000 of funding to DRP projects annually and
anticipate that each year we will fund about 3 one-year projects. The progress of all DRP projects will be
monitored regularly with respect to achieving their specific aims and milestones using clearly defined
evaluation criteria (Aim 4). Of particular interest will be the potential of each project to advance to a full SPORE
Project. We will also track long-term reportable outcomes of each project such as peer-reviewed manuscripts,
oral presentations and grant funding.

Public health relevance
Project Narrative The DRP is a key component of the long-term success of our overall Program. It will fund innovative developmental projects focused on translational cancer disparities research with the potential to develop into Full Projects for our subsequent P50 SPORE grant application.